HIV-1 Gene Suppression by CD8+ T Cells

DESCRIPTION (provided by applicant): Our overall goal is to define the properties of anti-viral CD8+ T cells that should be elicited by an efficacious HIV-1 vaccine. Indeed, an NIH-sponsored, phase IIb, proof-of-concept trial was initiated specifically to test whether a multi-clade Env+Gag prime-boost strategy elicits HIV-1 specific CD8+ T lymphocyte responses that can reduce viral load in those who become infected with HIV-1. Some aspects of CD8+ immune responses have been reproducibly associated with virus control. However, a recently completed HIV-1 vaccine trial elicited HIV-specific CD8 T cells with no effect on viral control. These studies underscore the critical need to evaluate surrogate markers of virus inhibitory CD8+ T cell responses in assessing vaccine efficacy. The precise mechanisms underpinning the ability of CD8+ T cells to inhibit virus replication must be defined in order to inform future trial design. We found that HIV-1 vaccination elicits CD8+ T cell mediated HIV-1 inhibition, and that CD107a and MIP-12 expression strongly associates with this antiviral CD8+ T cell response. Moreover, the antiviral CD8+ T cell response is modulated by epigenetic mechanisms, thereby providing a new paradigm for the induction of effective CD8+ T cell responses. This project builds significantly upon our recently published work using the innovative combined strategies of CD8+ T cell virus inhibition assays, multiparameter flow cytometry with cell sorting, and molecular techniques to interrogate gene expression to characterize anti-viral HIV-1-specific CD8+ T cells and define the mechanisms underlying that inhibition. We will examine the phenotype and function of CD8+ T cells in four unique cohorts including elite controllers and HIV-1 vaccinees. Completion of the project will provide key data that will enable optimization of vaccine regimens to elicit CD8+ T cells capable of suppressing HIV-1.

Public health relevance
An appreciation for how the CD8 cells inhibit virus replication will guide strategies to induce these types of antiviral responses in future candidate HIV vaccines and could also potentially lead to the design of novel therapeutics. It is clear the initil viral set point is correlated with disease outcome and so strategies aimed toward decreasing the viral burden during acute infection will likely have beneficial outcomes for both a healthier individual clinical outcome and also at the population level by reducing the likelihood of transmission.